Epigenetic regulation of thrombopoiesis

PROJECT SUMMARY
Platelets are critical for hemostasis, thrombosis and inflammatory responses. Billions of platelets circulate in
mammalian blood to prevent blood loss in case of tissue injury. The lifespan of platelets is short (5-9 days in
humans); as a consequence, several million platelets have to be produced every hour to maintain their
physiological blood counts and to avoid the risk of bleeding. Platelets are generated in the bone marrow from
megakaryocytes that, in turn, develop from hematopoietic stem and progenitor cells (HSPCs). Although
important signaling pathways and transcription factors have been shown to play important roles in platelet
biogenesis (thrombopoiesis), little is known about the epigenetic regulation of this process and the key
epigenetic regulators involved. Because epigenetic regulators are essential components of regulatory networks
that act collaboratively with transcription factors during cellular differentiation, lack of such knowledge
significantly hinders the elucidation of the molecular networks controlling platelet generation and function. We
have published significant work on the MLL3/4 (mixed lineage leukemia 3&4; KMT2C/KMT2D) histone
methyltransferase (KMT) complex, including uncovering an important role for MLL4 in myeloid leukemia, a role
for the MLL3/4 complex adaptor subunit PTIP (Pax interaction with transcription-activation domain protein-1) in
lymphocyte class switch recombination and, recently, in maintaining normal and leukemic hematopoietic stem
cell niches. For the latter studies, we have generated a mouse model of conditional inactivation of PTIP in
HSPCs and consistently observed that PTIP deficiency led to thrombocytopenia. We recently generated a MK-
specific mouse model and established that the observed reduction in platelets is an intrinsic effect of PTIP
deletion in the MK lineage. Preliminary analysis performed on MLL4-deficient mice revealed mild, but
significant, thrombocytopenia. Based on our preliminary data and published work, we hypothesize that PTIP is
required for platelet generation by functioning together with MLL3 and MLL4 to direct a thrombopoiesis-specific
gene expression program. The objective of this project is to determine the role of PTIP and its associated
KMTs MLL3/4 in platelet generation. Results from the proposed studies are expected to fundamentally
advance the fields of platelet biology by further defining the epigenetic mechanisms that regulate platelet
generation. Finally, results from our work will likely contribute to the development of novel in vivo therapies
aimed at enhancing platelet production or ex vivo expansion of platelets. Our long-term goal is to harness the
reversibility of post-translation modifications of histones to promote human health.
!

Public health relevance
PROJECT NARRATIVE The lifespan of platelets is short (5-9 days in humans) and, as a consequence, several million platelets have to be produced every hour to maintain their physiological blood counts and to avoid the risk of bleeding. Therefore, the elucidation of the regulatory mechanisms involved in platelet generation from megakaryocytes is crucial in health as well as disease. Using mouse models, we will determine the role of specific factors that modify the chromatin (and therefore the expression of specific genes) in megakaryocytes and provide novel targets that may aid in the future ex vivo expansion of platelets and in vivo therapies aimed at enhancing platelet production.